Integrating EEG/MEG and fMRI: 99-M-0172

Development of MEG data recording and signal processing methods has been very successful. Studies of working memory tasks and auditory processing tasks have shown the ability to localize brain activation and to address issues of phasic versus tonic activity. We have also begun to investigate phenotype measures that will be applicable in many related studies and specifically the sibling project. We are now studying almost all subjects admitted thru the sibling project.[unreadable] [unreadable] MEG recording during cognitive activation has shown the ability to localize in very comparable fashion to fMRI. Specifically beta desynchronization at the cortical level has been found to agree with BOLD activation results. However, the MEG/EEG allows for temporal information not possible with other imaging techniques. Phasic relationships across brain areas have been demonstrated using advanced signal processing techniques. Our results to date show that measures of brain structure and function represent powerful tools to find susceptibility genes.